Mechanical Modulation of Cell Migrations by DNA Nanoassemblies

Summary. In this project, we will exploit mechanical properties of self-assembled DNA nanostructures to
modulate cell migrations. Cell migration represents a fundamental process in biological functions of almost all
multicellular organisms. Numerous diseases occur if cell migrations are not adequately regulated. We will
modulate the cell migration by mechanically interfering with lateral clustering or declustering of transmembrane
integrin receptors, which is a mechano-transduction process following the binding of the ligand (e.g. RGD) to
the integrin and characterized by the association of the integrin to the actin fibers important for cell motions.
We will fabricate DNA origami nanoassemblies, DNA nanosprings, for this modulation. By placing discrete
piers in an extended template of DNA helix bundles, the DNA origami template will bend into coils of a
nanospring when adjacent piers are brought together by compact DNA linkers formed between piers. We plan
to use these DNA nanosprings as nanometer force gauges to monitor both compressive and tensile lateral
forces for the clustering and declustering of integrin receptors, respectively, on cell membranes. To serve as
force gauges, we will first determine the spring constant of nanosprings in optical tweezers. We will then
evaluate the extension change of the nanospring under external force using FRET dye pairs. By multiplication
of these two variables according to the Hooke’s law, we will reveal the force experienced by the nanospring.
To modulate cell migration, we will adjust the spacing of RGD molecules anchored on DNA nanosprings by
coiling and uncoiling of nanosprings under environmental cues. Since RGD can bind to the integrin on a cell
membrane, the spacing of RGD on nanosprings allows to cluster/de-cluster integrin receptors. In the first
approach, we will use DNA i-motif as a chemo(pH)-responsive linker in the DNA nanospring. Slight acidity folds
i-motif in the linker, which coils the nanospring and shortens spacing of RGD to cluster integrins. Such a
nanospring will therefore inhibit migrations of cancer cells in slightly acidic extracellular matrix. At or above pH7,
nanosprings are coiled after duplex DNA is formed in the linker region. When complementary oligonucleotides
are applied to remove one of the duplex strands in the linker, the nanospring is uncoiled, which elongates RGD
spacing. This will promote migrations of cells such as human macrophages that play important roles to heal
skin wounds. The skin surface also permits the use of the light without deep penetration on topically applied
nanosprings. For this opto-mechanical modulation, we will incorporate light-sensitive azobenzene groups in the
linkers of DNA nanosprings. Using the light with different wavelengths, the azobenzene undergoes cis/trans
isomerization. This varies DNA linker length between neighboring piers, changing RGD spacing via coiling or
uncoiling the DNA nanospring. We have successfully demonstrated the feasibility of this strategy in the cell
spread and migration assays. In the proposal, we will use these assays to test the effects of nanosprings with
different mechanical properties (Aim 1) on migrations of HeLa cells (Aim 2) and human macrophages (Aim 3).

Public health relevance
Project Narrative This project will test strategies to modulate cell migrations using mechanical actuation that is responsive to chemical (pH and oligonucleotides) environment and light of different colors. The project will also design a force gauge to measure mechanical force involved in the cell migration processes. The knowledge obtained will help to heal skin wounds and fight various diseases associated with abnormal cell migrations.